Functional restoration of ventriculo-arterial coupling in cardiogenic shock via dual mechanical support

PROJECT SUMMARY
Cardiogenic shock is a highly morbid condition - impaired heart function leads to multi-organ failure and death.
Even prompt medical therapy is frequently insufficient and mechanical means of supporting the circulation are
increasingly evolving. Extracorporeal membrane oxygenation (ECMO) has rapidly been embraced to provide
mechanical circulatory support but limited understanding of its impact on left ventricular function restricts its use.
ECMO profoundly disrupts coupling between the left ventricle and the arterial system through introduction of
retrograde perfusion that collides with antegrade blood flow from the failing heart to generate a dynamic
watershed region whose impact on end-organ perfusion and clinical outcomes is unknown.
Recent clinical studies report improved outcomes for ECMO patients when paired with a percutaneous
ventricular assist device (pVAD) to provide for dual mechanical support. Intriguingly this idea mirrors our own
clinical observations in which addition of a pVAD allows for offloading of the left ventricle and improved clinician
control of perfusion. We recently harnessed metrics of interactions between the heart (host) and pVAD (device)
in cardiogenic shock to provide insight into the physiological state of the failing heart and parameters that can
be utilized to track changes in organ function. We have linked pVAD support to ECMO and have discovered that
changes in pVAD operation identify organ recovery or disease progression. We have further investigated the
effects of ECMO on blood flow utilizing computational fluid dynamic modeling to quantify flow disruptions induced
by the introduction of retrograde perfusion.
We hypothesize that dynamic watershed regions affect end-organ perfusion and that pVADs allow for clinician-
controlled modulation of the circulation thereby functionally restoring ventriculo-arterial coupling. We investigate
this hypothesis by: (1) determining ECMO effects on left ventricular function; (2) quantifying vascular flow
dynamics in the ECMO-failing heart circulation; and (3) investigating the effect of dual mechanical support with
ECMO and a pVAD on LV function and vascular flow dynamics. We apply multiscale multimodal methods to
evaluate our hypothesis. We will study the effects of ECMO and then dual mechanical support on LV function in
the intact pig and in studies of patients with cardiogenic shock. We will investigate vascular dynamics utilizing
computational fluid dynamics and benchtop models of the ECMO-failing heart circulation. Our findings will yield
insight into the application and optimization of ECMO support to improve clinical outcomes and device design.
This project makes the most of my clinical interest in shock and mechanical support, engineering background,
and research in multiscale pathophysiologic systems. With the guidance of enlightened mentors and an advisory
committee, I have developed a five-year plan to provide the didactic and research training I need to become a
successful independent investigator focused on the development of advanced mechanical support of end-stage
cardiopulmonary disease.

Public health relevance
PROJECT NARRATIVE ECMO has rapidly been adopted to provide mechanical circulatory support for cardiogenic shock patients despite limited understanding of its impact on left ventricular function and its dysregulation of left ventricular coupling to the arterial vasculature. We propose to determine the effect of ECMO on left ventricular function and end organ perfusion and to investigate use of a percutaneous ventricular assist device to unload the left ventricle and functionally restore ventriculo‐ arterial coupling.